Research Training for Neurosurgery and Neurology Residents & Fellows

The purpose of this R25 Research Education Program is to provide mentorship and guidance, in addition to
protected time and resources, to diverse and outstanding Neurosurgery and Neurology residents. These
mentees will have access to faculty across three departments at The University of Texas Health Science
Center at Houston – the Department of Neurosurgery, the Department of Neurology and the Department of
Anatomy and Neurobiology. The unique elements of our program include (1) novel entrance criteria designed
to attract residents with a strong track record of basic science research, (2) mandatory participation in
UTHealth's 2-year Masters of Clinical Research Curriculum, (3) financial support for a full-time technician for 2
years after the resident completes their first R25 year to ensure that their project is followed through to
completion, and (4) an additional year of protected, non-clinical research. The location of this proposed grant,
at UTHealth, is also a major benefit as this institution is located in the heart of The Texas Medical Center in
Houston, one of the most diverse city in the USA and one whose population is growing rapidly. The mentoring
of a greater number of clinician-scientists at our institution will transform the research landscape as it combines
our major strengths in basic research with a proven track record of clinical excellence.

Public health relevance
The care of future generations depends crucially on training the next generation of innovators in the clinical sciences. We propose a mentored training grant at the McGovern Medical School at UT Health for residents in neurology and neurosurgery that will attract the best and brightest and create the next generation of leaders in academic clinical neurosciences.